Problematic avoidant/restrictive eating in adults with functional dyspepsia: the role of endogenous oxytocin and glucagon-like peptide 1

PROJECT SUMMARY/ABSTRACT
Functional dyspepsia (FD) is a chronic gastrointestinal functional/motility disorder that affects up to 12% of US
adults with significant morbidity and healthcare costs, and limited treatment options. Detrimental eating-related
medical consequences are frequent in FD, with a level of food avoidance/restriction meeting criteria for
avoidant/restrictive food intake disorder (ARFID) in up to 40% of adults with FD. However, the biological
mechanisms of problematic avoidant/restrictive eating in FD have been underexplored and could inform
behavioral and biological intervention targets. The parent K23-Patient-Oriented Research Career Development
award addresses this research gap by using an innovative, multi-disciplinary approach to examine the
mechanistic role of problematic avoidant/restrictive eating in FD and the potential benefit of a behavioral
intervention that exposes patients with FD to increased food volume/variety. Our team’s uncontrolled pilot data
suggest that the behavioral treatment can improve FD. In the parent K23-supported studies, Dr. Burton-Murray
is studying anorexigenic cholecystokinin and peptide YY as candidate mechanisms of ARFID in FD that may
be modifiable. The R03 is a discrete, well-defined project that will expand the K23 research objectives with the
evaluation of two additional candidate anorexigenic hormones, oxytocin and glucagon-like peptide 1 (GLP-1).
Biospecimens are collected from two parent K23-supported studies—an observational cross-sectional study
and a pilot feasibility randomized controlled trial of a behavioral treatment. As the first evaluation to our
knowledge of endogenous oxytocin and GLP-1 in FD the study aims to: (1) identify if oxytocin and GLP-1 are
additional biomarkers associated with problematic avoidant/restrictive eating in adults with FD, and (2)
characterize preliminary candidate mechanisms of action in a behavioral treatment for adults with FD and
ARFID. The R03 study aims complement Dr. Burton-Murray’s K23 training objectives in examining endocrine
regulation of appetite in FD. Findings from the proposed project will support Dr. Burton Murray’s K-to-R
transition as an independent R01-funded researcher, informing candidate appetite hormones to investigate as
mechanisms of action in a behavioral treatment for FD in a next-step R01.

Public health relevance
PROJECT NARRATIVE Functional dyspepsia (FD) is a chronic gastrointestinal functional/motility disorder which frequently poses detrimental and problematic eating-related medical consequences (e.g., significant weight loss, malnutrition) with avoidant/restrictive food intake disorder (ARFID) present in up to 40% of adults with FD. While treatment options for FD are limited, presence of problematic avoidant/restrictive food intake has not yet been explored to inform treatment approaches and our team’s uncontrolled preliminary data suggest that an exposure-based cognitive-behavioral treatment can improve FD outcomes. The proposed multi- disciplinary study is a discrete, well-defined project that will expand the parent K23 research objectives to determine the role of problematic avoidant/restrictive food intake by (1) comparing levels of satiety- promoting oxytocin and glucagon-like peptide 1 among adults with FD and ARFID, FD without ARFID, and healthy controls, and (2) evaluating rates of change in the hormones in an exposure-based cognitive- behavioral treatment being studied in a randomized controlled trial for adults with FD and ARFID.